Multi-site EMR data ingest through FHIR: A case study for the RDCRN

Project Summary
This administrative supplement to the Data Management and Coordinating Center (DMCC) of the Rare
Diseases Clinical Research Network (RDCRN) proposes to design, implement and test new software to
enable the ingestion and quality control of multi-site Electronic Medical Records (EMR) data into natural
history study databases. The proposed technical solution is based on Fast Healthcare Interoperability
Resources (FHIR) interfaces to EMR systems as well as the REDCap database infrastructure already
operating in the RDCRN DMCC’s cloud environment. Over the one year performance period we will engage
with the CEGIR consortium and the EMR teams at Cincinnati Children’s and at least one additional site to
demonstrate feasibility of our proposed approach, with the long-term goal of enabling EMR data flow into
natural history research databases for all RDCRN consortia. Other potential long-term implications include
potentially significantly lower cost of data acquisition, increased standardization of data elements for RDCRN
studies and increased availability of FAIR (findable, accessible, interoperable and reusable) data in the
RDCRN’s long-term Data Repository.
The work proposed here is a natural extension of the DMCC’s mission to provide data acquisition, storage
and analysis tools for rare disease researchers.

Public health relevance
Project Narrative This administrative supplement to the Data Management and Coordinating Center (DMCC) of the Rare Diseases Clinical Research Network (RDCRN) will design, implement, and test new software that will leverage HL7 FHIR interfaces to extract structured medical records data to supplement natural history studies for rare diseases. We will assess technical feasibility and data quality by engaging two sites for one existing rare diseases consortium. Furthermore, we will devise and document best practices with a focus on scalability and reusability. Ultimately, a successful completion of this project will 1) enable the RDCRN to reduce the cost of data acquisition and 2) increase the availability of reusable and interoperable data shared by the RDCRN.